Assessing effects of adverse Social Determinants of Health (SDOH) in TTR V122l carriers via Structured data and Natural Language Processing (NLP) extraction, a comparison

The research project has two goals. The first is to use natural language processing (NLP) to
improve the identification of adverse social determinants of health (SDOH) in patients with a
specific genetic mutation. This is important because many social factors are only captured in
unstructured medical narratives, and NLP can help identify these factors more accurately than
the current method of using specific codes. The second goal is to investigate whether adverse
SDOH are associated with poor health outcomes in patients with this mutation. The researchers
will look at patients' medical records to identify adverse SDOH and compare their health
outcomes to those without adverse SDOH. The researchers hypothesize that adverse SDOH will
be associated with worse outcomes, and that more adverse SDOH will be associated with even
worse outcomes. However, the study has limitations, including relying on only one NLP tool and
using a binary definition of adverse SDOH. Future studies may address these limitations by
using different methodologies and more granular data.

Public health relevance
The TTR V122l gene exhibits incomplete penetrance despite its strong correlation with the development of severe HF. It is possible that social factors play a role in this complex process, but they have yet to be thoroughly investigated in this group. By utilizing NLP, this study aims to identify adverse social determinants of health (SDOH) in carriers on a large scale and evaluate their impact on clinical outcomes. This critical endeavor is essential for validating the feasibility of NLP extraction for SDOH, constructing more comprehensive models of disease progression, comprehending incomplete penetrance, and devising innovative management approaches.